Hormonal control of stem cells in the Drosophila ovary

PROJECT SUMMARY/ABSTRACT
Stem cells endow tissues the ability to replace cells and maintain cellular diversity during remodeling or
damage. Stem cells depend on both hormones and local signaling to regulate their activity in response to
physiological demand. The molecular mechanisms by which this spatiotemporal regulation is achieved,
however, are incompletely defined. To address this knowledge gap, our research program uses a well-
described stem cell-based tissue, the Drosophila melanogaster ovary, to elucidate the molecular mechanisms
underlying stem cell homeostasis. Ovarian germline stem cell (GSC) activity is governed by intrinsic cell cycle
regulators and local bone morphogenetic protein ligands from adjacent somatic cells. Yet we and others
demonstrated that GSCs are also responsive to the steroid hormone ecdysone, which is synthesized by
differentiated ovarian cells and essential for ovarian function. Previous studies were unable to disentangle the
pleiotropic effects of ecdysone, precluding identification of relevant molecular mechanisms in GSCs. Moreover,
while ecdysone is the sole ligand for the Ecdysone Receptor (EcR), other nuclear receptors are also ecdysone-
responsive, likely as transcriptional targets of EcR. The goal of our research program is to elucidate how GSCs
integrate the ecdysone response with intrinsic cell cycle regulators and local signals from neighboring soma to
successfully maintain stem cell homeostasis. In this proposal, we use novel genetic reagents for the
manipulation of EcR specifically in GSCs with a combination of quantitative high resolution fixed imaging, live
imaging, and single cell transcriptomics to identify the cell-autonomous mechanisms by which EcR controls
asymmetric division. We focus on how EcR transcriptional targets 1) directly promote intrinsic cell cycle
progression and the distribution of asymmetric determinants during mitosis, and 2) modulate the
responsiveness of GSCs to other extrinsic signals. Overall, the proposed projects will provide fundamental
insight into how a single steroid hormone can endow stem cells with the capacity to incorporate and respond to
diverse signaling inputs, providing a sensitive response system that ensures stem cell longevity and continued
production of differentiated progeny. Further, this work will inform future studies focused on elaborating the
gene regulatory network that controls stem cell asymmetric division.

Public health relevance
PROJECT NARRATIVE Tissue-resident stem cells maintain cellular diversity during tissue repair and remodeling. Yet how stem cells incorporate endocrine signals with the intrinsic mechanisms that guide asymmetric cell division is incompletely defined. Using a powerful genetic model, this proposal will elucidate how a steroid hormone provides sensitive molecular control over the gene regulatory network that controls stem cell division.